2023 Catecholamines Gordon Research Conference and Gordon Research Seminar

Project Summary
The 2023 Gordon Research Conference and Seminar on Catecholamines will take place at Rey Don Jaime
Grand Hotel in Castelldefels, Spain. This conference of no more than 200 registered attendees, held every other
year, is an ideal forum for exploring new developments in the field of catecholamines. It is also an excellent
opportunity for junior investigators and trainees to interact with established investigators in a relaxed and
scientifically stimulating atmosphere. The evaluations of recent conferences highlight the strong impact this
meeting typically has on emerging as well as established scientists. As the funds provided by the Gordon
Conference organization to each conference are limited, we are requesting funding from other sources. We are
hoping that the results of our requests enable us to support speakers and discussion leaders as well as junior
investigators and under-represented minorities to participate in the meeting. The conference will include one
plenary talk, by Dr. Carmen Sandi, as well as a young investigator session. The preliminary program includes a
large number of junior scientists, women, and scientists from historically unrepresented groups such as Black
and Indigenous People of Color (BIPOC). The GRC sessions planned include: 1) Molecular Genetics and
Epigenetics of Catecholamine Neurons, 2) Molecular Pharmacology and Signaling in Catecholamine Systems,
3) New tools to Probe Catecholaminergic Function, 4) Catecholamine Signaling in Naturalistic Behaviors, 5)
Heterogeneity in Catecholamine Encoding During Learning, 6) Catecholamines, Actions, and Movements, and
7) Catecholamines in Stress and Addiction. Two plenary sessions are also included, totaling nine sessions at
the GRC. The themes covered in the 2023 Gordon Conference on Catecholamines are highly relevant to
understanding the neurobiological bases of drug addiction as well as neurological diseases of movement and
neuropsychiatric disorders. This forum will provide a unique opportunity to discuss recent advances in the
understanding of how catecholamine systems may contribute to the pathophysiology and treatment of those
conditions. The preceding GRS held at the same location aid in bringing a large proportion of junior investigators
and graduate students and postdocs participants, to ensure that both the seminar and conference may have an
impact on how future generations of neuroscientists view these issues.

Public health relevance
Project Narrative The catecholamines dopamine (DA), norepinephrine (NE) and epinephrine play critical roles in the peripheral and central nervous systems, and alterations in catecholamine function contribute to human diseases including neuropsychiatric (drug addiction, schizophrenia, depression), neurological (Parkinson's disease, Alzheimer's disease), and cardiovascular disease. The 2023 Catecholamine Gordon Conference and Seminar will highlight leading research in catecholamine neurobiology as well as in catecholamine function and dysfunction that can lead to novel advances in our understanding of human diseases.